Orthognathic speech pathology: Understanding how jaw disharmonies and their surgical correction influence speech

ABSTRACT
Scientific Approach: Patients with severe dentofacial disharmonies (DFD; jaw disharmonies) seek orthognathic
surgery and orthodontic care to address issues with mastication, esthetics and speech. Preliminary data from
thousands of DFD patients generated by our colleagues at UNC-CH indicate speech concerns surpass impaired
chewing function as a motivator for surgery. Due to limited studies, we, as providers, are unable to give evidence-
based recommendations as to whether our orthodontic and surgical interventions will address speech disorders
associated with DFD. Despite limited data, patients undergo invasive jaw surgery in hopes of speech
improvement. To address this gap in knowledge, we have gathered surgical records and pre-operative audio
recordings of patients with DFD to quantitatively characterize their speech. In this proposal, we present
preliminary data identifying anatomical thresholds for significant articulation errors. Based on these data, we
hypothesize that speech distortions correlate with severity of anterior-posterior and vertical jaw
disharmonies, and that corrective surgery yields long-term improvement in speech. We propose the
following aims to address this hypothesis and explore the relationship between correction of jaw disharmonies
and speech. Aim 1: To examine the relationship between underbite (Class III) and open bite jaw disharmonies,
and speech distortion. Aim 2: To assess short- and long-term effects of corrective orthognathic surgery on
speech distortion in patients with underbite and open bite.
Training approach: Dr. Jacox is a dual-trained clinician-scientist, who completed dental school in parallel with
graduate school at Harvard School of Dental Medicine (HSDM- DMD) and Graduate School of Arts and Sciences
(GSAS- PhD). In addition, she is a certified diplomate of the American Board of Orthodontics. Her research
program and focus of this application was inspired by a patient seeking treatment `to help her talk
normally', whereby an evidence-based treatment option was not clear. The mentoring plan for this K08
award is designed to ensure Dr. Jacox will be a well-rounded and successful independent clinician-scientist
following completion of the activities in this proposal. Dr. Jacox has assembled a strong mentoring team to guide
her professional development and the establishment of her independent research program. Two co-mentors and
four consultants from diverse yet appropriate scientific and professional backgrounds will assist in the completion
of the training and scientific activities. Scientific interactions as well as didactic training in speech science and
technologies of speech science will add to Dr. Jacox's strong foundation in clinical orthodontics and the biology
of dentofacial disharmonies. These growth opportunities will allow for successful completion of the proposed
experiments, while the professional development activities will complement the training activities and provide Dr.
Jacox with skills necessary to thrive in academics and launch her independent research program.

Public health relevance
NARRATIVE Patients with disproportional jaws have underbites or open bites and suffer from speech disorders twenty times more than the general public, whereby these patients seek jaw surgery and braces to treat issues heavily impacting their quality of life, including abnormal chewing, facial esthetics, and speech. However, it is unclear why these patients present with a high prevalence of articulation issues and whether surgically correcting their jaws will improve their speech problems; as such, we as providers cannot provide evidence-based treatment recommendations. To address this gap in knowledge, we will use state-of-the-art technologies to longitudinally track speech changes pre- and post-operatively to evaluate outcomes of treatment and generate evidence- based care recommendations.